Effects of the DASH diet on glucose patterns in adults with type 2 diabetes

Abstract
The proposed grant is an approved ancillary study to the Dietary Approaches to Stop Hypertension for
Diabetes Trial (DASH4D), a randomized clinical trial being conducted at Johns Hopkins University. The
overarching goal of this ancillary study is to evaluate how a controlled diet (as part of this feeding study)
modifies glucose control and glycemic variability in black and white adults with type 2 diabetes. The objective
of the DASH4D trial is to determine the effects, alone and combined, of (a) the DASH4D diet (a DASH-style
diet modified for people with type 2 diabetes) vs. comparison diet typical of what many Americans eat and (b)
lower sodium intake vs. higher sodium intake on blood pressure among people with type 2 diabetes and
elevated blood pressure. The core design is a single-site, 4-period, crossover feeding study with 5-week
periods. Participants will be fed each of four isocaloric diets in random order. The proposed ancillary study will
add continuous glucose monitoring and laboratory testing of complementary biomarkers in all participants in
the DASH4D trial during two weeks of each of the four feeding periods. Our overarching goal is to answer the
question: Does a diet rich in fruits and vegetables improve glucose control and reduce glycemic variability in
adults with type 2 diabetes?

Public health relevance
Narrative It is unknown if the DASH eating pattern, a diet rich in fruits and vegetables, can improve glucose control and reduce glycemic variability in adults with type 2 diabetes. We will address this gap in the literature using a randomized clinical trial design. The results of this study will inform dietary recommendations in patients with diabetes.